The molecular and cellular basis of short-range host cue sensing in mosquito vectors

PROJECT SUMMARY/ABSTRACT
Mosquito disease transmission relies on the insect’s ability to feed on human hosts, a behavior driven by host-
associated sensory cues. Temperature and humidity are key short-range cues that promote the final stages of
host approach and biting, but little is known about the molecular and cellular basis of mosquito responses to
these cues, or whether these mechanisms are conserved among evolutionarily distant mosquitoes.
We propose to address these knowledge gaps by: 1) Probing the molecular basis and evolutionary conservation
of heat-seeking between the malaria vector Anopheles gambiae (An. gambiae) and the dengue vector Aedes
aegypti (Ae. aegypti). 2) Investigating the (as yet unknown) molecular and cellular basis of mosquito humidity
sensation in An. gambiae. We propose to achieve these goals in three aims:
Aim 1) Probe the evolutionary conservation of heat seeking mechanisms. Mosquito blood-feeding
is thought to have a common evolutionary origin, but whether the mechanisms that control heat-seeking are
conserved across mosquitoes is an open question. We will test this conservation by comparing the roles of key
receptors implicated in heat-seeking in multiple mosquito species in order to reveal whether and in what ways
heat-seeking mechanisms are shared across vector mosquitoes.
Aim 2) Determine the sensory specificities of candidate humidity receptor-expressing neurons
in An. gambiae. Despite its importance for host seeking, mosquito humidity sensing is largely unexplored.
We will test the hypothesis that mosquito humidity sensors rely on relatives of receptors important for sensing
humidity in Drosophila. We will examine the stimulus sensitivities of the sensory neurons expressing these
receptors and test the role(s) of these receptors in detecting sensory stimuli.
Aim 3) Establish the behavioral roles of candidate hygroin An. gambiae. We will test how our
candidate receptors for humidity and temperature contribute to the mosquito’s behavioral responses to
humidity and temperature, as well as host seeking and blood feeding. We will also compare how host-seeking
roles relate to homeostatic roles in helping modulate body temperature and hydration state.
This work will identify molecular receptors and sensory neurons that detect temperature and humidity in
vector mosquitoes and establish their roles in mosquito host seeking and blood feeding. As these behaviors
supports disease transmission, these basic science findings have potential relevance for vector control efforts.

Public health relevance
NARRATIVE This work will identify the molecular receptors and sensory neurons that disease vector mosquitoes use to detect the body heat and humidity from human hosts, and establish their roles in promoting mosquito blood- feeding. As blood-feeding supports disease transmission, these basic science findings have potential relevance for vector control efforts by, for example, identifying molecular and cellular targets for developing new chemical repellents, masks or baits.